Mechanisms of Sex Determination in Zebrafish

The Problem: Differences in (or Disorders of) Sex Development (DSD) are complex medical issues that
involve multiple interacting cell types and organ systems. DSDs impact disease susceptibility, psychological
development, and sense of person. Knowledge of mechanisms by which genetic factors interact with each
other and with the environment to direct sex determination (SD), however, is incomplete. Zebrafish is an
important medical model with a SD system that is sensitive to unidentified genetic variation and poorly
understood environmental influences. Our research showed that zebrafish lab strains have weak,
polymorphic, or non-genetic SD mechanisms, but natural zebrafish from India have a single, strong Sex-
Associated Region on chromosome-4 (sar4) with chromosomally ZZ males and ZW females. ZZ fish are
always males and most ZW fish are females, but a minority are fertile `neomales', likely due to genetic
modifiers or environmental factors. Rare WW fish can be either males or females. We and others have
made mutations in many candidate SD genes, but none represent the sar4 SD factor. We also showed that
meiotic oocytes are necessary in lab strains to maintain female development, presumably by sending a
signal to the gonadal soma. Our overall goals are to identify the molecular genetic basis of the sar4 sex
determinant, and to discover its molecular, cellular, and organ level mechanisms to direct male or female
development. Under one hypothesis, sar4-W has a dominant, variably penetrant, female-determining gene.
An alternative hypothesis invokes sar4-Z dosage, with two doses resulting in a male and one dose or no
doses usually giving females. In either case, we want to know how it specifies sex. In preliminary results,
we: 1) collected four independently derived strains with the natural sar4 SD mechanism; 2) made genome
assemblies for several natural strains; 3) developed PCR primers to assay sar4-Z and sar4-W; 4) made
Bacterial Artificial Chromosomes (BACs) for ZZ and for ZW fish and isolated many sar4 BACs; and 5)
performed single-cell RNA-seq on ZZ and ZW genotypes, which identified ZZ- and ZW-specific cell clusters.
A comparison of sar4-Z to sar4-W identified a large recombination-suppressing inversion, many indels, and
other polymorphisms. The overall vision of the research program is to manipulate genomes and
environments to uncover the mysteries of zebrafish SD. Work includes: 1) identifying SD factor(s) in sar4 by
performing necessity experiments that examine the effects of CRISPR/Cas9-induced long deletions and
targeted knockouts on SD and sufficiency experiments using BAC transgenesis to identify clones that alter
SD; and 2) to learn the pathways of male and female SD in zebrafish by single-cell gene expression studies
in a variety of developmental stages, mutant genotypes, and environmental manipulations in ZZ and ZW
fish. The significance will be a better understanding of gene interactions and environmental influences on
zebrafish sex determination that will inform human DSDs.

Public health relevance
Project Narrative The mechanisms of sex determination are an important and complex medical issue that involves multiple interacting cell types, several organs, and impacts susceptibility to disease, psychological development, and sense of person. We lack, however, full knowledge of how various genetic factors interact with the environment and its contaminants to direct sex determination. Because zebrafish is an important medical model with a sex- determination system that is sensitive to unidentified genetic variation and poorly understood environmental influences, we propose a research program to discover the developmental genetic basis for zebrafish sex determination.